Neurexin Isoforms in Retina Structure and Function

The long-term goal of this project is understand the molecular interactome that establishes and maintains
highly specialized retinal cell interactions that establish parallel pathways within the retina. The focus in this
proposal is to determine the function of 3 Neurexin genes and their isoform specific expression pattern within
the retina. Neurexins are trans-synaptic organizers that interact with several ligands and are important in
establishing functional properties at excitatory and inhibitory synapses. Neurexins undergo extensive
alternative splicing creating potentially hundreds of isoforms, which are known to be important in disease.
However to date the role of this important class of protein in retina is unexplored. Emerging technologies ow
make it possible to obtain a more complete picture of isoform structure in a tissue and/or specific cell types
within a tissue. Therefore in the project we will,1) Determine the function of Neurexins in the retina, and 2)
determine the retinal cell type expression pattern of Neurexin isoforms using single cell iso-Seq.
At the completion of this project, we will have characterized, for the first time, the cell class specific
expression of neurexins and their role in maintaining the structure and/or function of the first retinal synapse.

Public health relevance
Retinal function requires the accurate assembly of synapses between cells in in a cell type specific to create parallel vertical pathways that transmit various aspects of the visual scene to higher brain structures. The studies in this proposal will characterize the function and cell type isoform distribution of one family of adhesion molecules that has the potential to set up a cell type code, Neurexins, and which are likely critical to visual function.